Circuit-specific catecholamine regulation of sensitivity to delayed punishment

Abstract
A fundamental characteristic of substance use disorder (SUD) is ongoing drug seeking and misuse despite
physical, financial, and legal consequences. Critically, aversive consequences following a substantial delay,
such as withdrawal after substance use, are often underestimated. Despite the common occurrence of delayed
punishment, cost/benefit decision-making research has focused almost entirely on punishment occurring
immediately after a choice. To address this gap, we developed the Delayed Punishment Decision-making Task
(DPDT), which reveals that rats, like humans, underestimate or “discount” the negative value of delayed
punishment during decision-making. Preliminary data obtained using DPDT reveal that orbitofrontal cortex
(OFC) inactivation increases sensitivity to delayed punishment, and OFC encodes information about
punishment delay prior to choice. While these data suggest a role of OFC in the assessment of delayed
punishment, the mechanism underlying this process remains unclear. OFC activity is sculpted by
catecholaminergic projections from distinct midbrain nuclei, specifically dopaminergic projections from the
ventral tegmental area (VTA) and noradrenergic projections from the locus coeruleus (LC). Our central
hypothesis is that sensitivity to delayed punishment is modulated by dopamine and norepinephrine projections
to OFC, with dopamine release from neurons arising from VTA affecting the discounting of delayed
punishment, and noradrenergic neurons from LC regulating sensitivity to punishment regardless of delay. We
will evaluate this using DREADDS for both circuit and cell-type specific manipulation of neural activity in LC or
VTA neurons projecting to OFC during DPDT. In Aim 1, we will use infuse inhibitory or excitatory DREADDS
into the VTA of TH-Cre rats, then directly stimulate these receptors in the OFC terminals prior to DPDT. This
will enable selective modulation of dopamine release in OFC. For Aim 2, we will infuse excitatory or inhibitory
DREADDS into LC, then stimulate these receptors in OFC prior to DPDT. For all manipulations in both Aims,
we will perform control experiments to confirm that manipulations are affecting sensitivity to immediate or
delayed punishment rather than pain tolerance, reward discrimination, or behavioral flexibility. Collectively,
these studies will determine a potential mechanism for how the OFC regulates sensitivity to both delayed and
immediate punishment. Moreover, these experiments will determine if direct manipulation of two understudied
neuronal circuits has efficacy as a potential treatment to improve sensitivity to delayed consequences in SUD.

Public health relevance
Project Narrative Negative consequences of substance use are often underestimated because they occur later in time. However, little is known about how the brain processes the threat of delayed punishment during decision-making. This project will investigate the role of two understudied neuronal circuits in regulating sensitivity to both delayed and immediate punishment, which may enable novel neurobiological treatments to improve decision-making in substance use disorders.